Alzheimer's disease pYGSK3 pathophysiology and PTPRD positive allosteric modulators

Project Summary/Abstract Alzheimer's disease (AD) receives pathogenic contributions from genetics [1, 2] and from environmental influences that include dietary intake of flavanols > flavones [4-8]. Neurofibrillary tangles (NFTs) rich in hyperphosphorylated tau protein [10] are prominent features of AD neuropathology. NFT densities correlate well with the degree of AD dementia [15] [18] and are influenced by variation in the ApoE and PTPRD genes [3]. One approach to altering tau/NFT pathophysiology is to reduce activities of the kinases that hyper- phosphorylate tau. The glycogen synthase kinases GSK3α and GSK3β are prominent tau phosphorylators [19]. GSK3α and GSK3β are activated by phosphorylation of their own tyrosines (pY279 and pY216) by known tyrosine kinases [20] [21, 22]. Increasing activity of tyrosine phosphatase(s) that dephosphorylate and reduce activities of brain GSK3α and GSK3β thus provides a novel approach to reducing tau pathology in AD. Evidence (much developed with support from our first NIA supplement) now supports roles for: a) the receptor type protein tyrosine phosphatase PTPRD as both a i) key physiological phosphatase for phospho (pY) GSK3α and GSK3β and ii) novel target for decreasing pathological AD tau hyper- phosphorylation and b) flavanols as lead compound PTPRD positive allosteric modulators (PAMs) that increase this desired PTPRD activity. We will enhance this evidence and move toward translation by testing hypotheses that a) increased PTPRD dephosphorylation of GSK3α and GSK3β reduces the activities of these tau-hyperphosphorylating kinases with specificity, underlying PTPRD's genetic associations with NFT densities in AD brains and b) flavanols whose intake reduces AD incidence in aging [4-8] serve as PAMs for PTPRD's phosphatase, increase GSK3 dephosphorylation with specificity and provide a pathway for development of improved, specific PTPRD PAMs that can reduce progression to AD deficits during aging. We will test these hypothesis and support development and translation of PTPRD PAMs in several ways: 1) we will characterize the specificity of PTPRD effects by comparing i: rates of PTPRD dephosphorylation of pYGSK3α and pYGSK3β and ii: quercetin effects on these rates vs those for each of > 80 candidate neuronal PTPRD substrates. 3) We will synthesize and test novel flavanol analogs as improved PTPRD PAMs, nominating novel structures by in silico docking to the PAM vs catalytic sites on PTPRD's phosphatase, testing these structures in vitro, refining our in silico models and nominating/synthesizing/testing new structures on the basis of these results. For the best candidate positive allosteric modulators, we will test specificities vs other PTPRD substrate phosphopeptides and off-target sites of action of currently marketed drugs. We will test the most promising PTPRD PAMs in vivo for gross, histological or behavioral toxicities, biodistribution (including brain) and target engagement. We will expand validation of quercetin effects in aging 3xTg- AD mice and initiate studies to test novel PTPRD PAM(s) in this model. This work will advance our understanding of AD pathophysiology, validate novel approaches to PTPRD positive allosteric modulation and provide a basis for development of interventions that can prevent and/or treat key aspects of AD pathophysiology.

Public health relevance
Narrative We will test the novel idea that PTPRD modulates the activities of the GSK3 α and β brain enzymes that hyperphosphorylate tau with specificity, changing vulnerability to Alzheimer's tau pathophysiology, providing sites for action of the flavanol positive allosteric modulators of PTPRD phosphatase activity that reduce Alzheimer's disease incidence and for novel PTPRD positive allosteric modulators that display higher potency and more uniform bioavailability. Results will provide new insights, reagents, improved AD models and drug candidates for a novel therapeutic target and strategy for Alzheimer's disease tau pathology.